Induction of interferon response by chromatin damaging anti-cancer therapy

Abstract. DNA-targeting drugs are a mainstream therapy for cancer, but it is becoming clearer that some of their
anti-cancer activity is due not only to DNA damage, but also chromatin decondensation, which we call chromatin
damage (CD). Moreover, it has been shown that some drugs cause only CD without DNA damage, and these
"CD-only" drugs are as potent anti-cancer drugs as compounds causing both CD and DNA damage, but lack the
toxicity associated with DNA damage. The focus of our study is to understand how CD activates IFN, and how
this property can be used in the clinic to gauge the potency of CD drugs. Our ultimate goal of our research is to
show that CD is a superior mechanism to DNA damage for the next generation of anti-cancer chemotherapy,
which is more effective, less toxic, and more powerful in activating an anti-tumor immune response.
To achieve this goal, we have developed a new group of "CD-only" chemicals, curaxins. The anti-cancer
activity of curaxin clinical lead, CBL0137, has been demonstrated in multiple mouse models. Phase I trial has
shown manageable toxicities and evidence of antitumor activity. These studies confirmed induction of IFN
signaling by CBL0137 in mice and humans. Notably, curaxins cause stronger and faster IFN induction than DNA
damaging agents, DNA methyltransferase inhibitors, and HDAC inhibitors. It is well established now that IFN
induction significantly improves their anti-cancer efficacy of DNA damaging therapy. CD causes IFN induction
via different mechanisms, but our data showed that IFN activation enhances anti-cancer efficacy of CD.
Therefore, we propose that anti-cancer activity of CD agents is mediated in vivo via two complementary
mechanisms: direct killing of tumor cells and engagement of anti-tumor immune attack. This proposal focuses
on the hypothesis that IFN signaling in tumor and/or non-tumor cells is induced by CD via a mechanism different
from DNA damage and potentiates the anti-cancer activity of CD drugs.
We will focus on triple negative breast cancer (TNBC), a challenging disease to treat due to its aggressive
behavior and lack of actionable targets. Our specific aims are: 1. Determine the impact of the IFN activation
in tumor and non-tumor cells on the anti-tumor activity of CD therapy. 2. Define the mechanisms of IFN
activation by CD agents. 3. Develop strategies for reversing the immune suppressive environment in
triple-negative breast cancer using CD agents.

Public health relevance
Project Narrative We have developed a group of novel anticancer chemicals, curaxins, which are currently tested in clinic; they act via disrupting of packaging of genetic material, DNA, in tumor cells. Contrary to exiting drugs targeting DNA they do not cause mutations. We recently identified a new feature of these compounds that they can activate immune response against tumors; in this proposal we will figure out how they do this and how we can utilize this property in the clinic to get maximal benefit for patients.